mtDNA phylogeny of the germ line: mechanism, structure and function of the mtDNA bottleneck

The principal function of mitochondria is the generation of cellular energy (ATP) by oxidative phosphorylation
using proteins encoded for by both the nuclear genome and the mitochondrial genome (mitochondrial DNA,
mtDNA) to assemble the machinery needed for mitochondrial respiration. Paradoxically, mtDNA is a
macromolecular target of reactive oxygen species (ROS), which are mutagenic by-products generated during
ATP production. Unlike nuclear DNA, which has a high-level of proofreading, error detection and correction that
coordinately function to prevent passage of harmful DNA mutations to offspring, mtDNA mutations are not
subject to the same degree of detection and correction. Indeed, past studies have shown that mtDNA sustains
a high mutational burden that progressively increases in cells with age. This paradigm raises a fundamentally
critical question when one considers that mitochondrial passage from one generation to the next is uniparental
through the female germline (egg): how are detrimental mtDNA mutations that accumulate in maternal germ
cells over time prevented from being passed to the next generation, the generation after that, and so on?
Two distinct, but likely interrelated, processes have been offered to explain this phenomenon – the mtDNA
bottleneck and germline-purifying selection. However, large gaps in knowledge still exist regarding both. For
example, several different mechanisms have been proposed for how the mtDNA bottleneck works – none of
which have been proven, and its position in germline development is debated. Likewise, it is not known where
germline-purifying selection takes place relative to the bottleneck or even if it depends on the bottleneck. We
recently developed an innovative technology combining PACBIO third-generation sequencing with unique
molecular identifiers, which enables high-fidelity mutational analysis of entire individual mtDNA molecules. With
this in hand, we are now uniquely positioned to map how transgenerational passage of high-quality mtDNA
molecules is accomplished. To do this, we propose the following Specific Aims (SAs). SA1: Define the structure
and dynamics of the mtDNA bottleneck. We will build detailed phylogenetic trees of mtDNA molecules within
individual germline cells, and compare these trees to those simulated from proposed bottleneck models. SA2:
Determine the timing and mechanisms of germline-purifying selection. We will compare ‘synonymity’ of
mutations from phylogenetic tree branches to identify when purifying selection occurs, and how it interfaces with
the bottleneck. SA3: Determine if individual mtDNA molecules carrying no/low versus high mutational
burdens are preferentially allocated during early (preimplantation) embryogenesis. We will evaluate
mtDNA genealogies in individual blastomeres of preimplantation embryos at the 2-, 4- and 8-cell stages, as well
as in the inner cell mass (embryo proper) and trophectoderm (extraembryonic) of blastocyst-stage
preimplantation embryos, to determine if there exists evidence of differential allocation of mtDNA mutations.

Public health relevance
As mitochondria – the factories for energy production in all cells (including eggs), perform their critical function, the precious genetic material contained within these cellular powerhouses (mtDNA) becomes progressively damaged by mutagenic by-products of energy production. With the vast majority of this damage not subject to repair, a basic question fundamental to the survival of every species (including humans) has arisen: how do mitochondria get passed from one generation to the next – a process managed through the egg, in such a way that offspring are born with a ‘clean’ population of mitochondria essentially free of damage? By developing an innovative new technology that enables identification and tracking of mtDNA damage (mutations), we are now uniquely positioned to more clearly elucidate the mechanisms by which eggs and the embryos they produce following fertilization actively work to prevent the passage of mitochondria containing damaged genetic material to offspring each successive generation.